Acid sensing associated mechanisms in AUD and comorbid panic

Project Summary/Abstract
Alcohol’s effects on the body are complex, altering behaviors, emotions and physiology. These effects all
contribute to the cycle of alcohol use and abuse that leads to alcohol use disorders (AUDs). They also
contribute to the development of comorbid psychiatric disorders, like panic disorder (PD), which are common.
Comorbidity is associated with worse patient outcomes, yet little is known regarding the pathophysiology
regulating comorbidity. Emerging evidence supports dysregulated acid-base homeostasis may be a shared
mechanism in AUD and PD. Maintaining physiological homeostasis (e.g. neutral pH) is critical for survival, and
threats to homeostasis elicit behavioral, emotional and physiological responses directed toward this goal.
Alcohol use induces acidosis which is positively correlated with withdrawal severity. Strong evidence supports
dysregulated acid-sensing in PD, but its role in AUDs is not well understood. Our lab recently found a role for a
novel microglial acid-sensor T-cell death associated gene 8 (TDAG8) in panic-relevant behavior and
physiology. Interestingly, preliminary data show ethanol increases TDAG8-promoter driven GFP expression
and neuroinflammation in a TDAG8 dependent manner. Thus, TDAG8 and associated neuroimmune effectors
may provide a unique and novel shared mechanism for AUD and PD. The purpose of this K99-R00 proposal is
to determine if TDAG8 regulates AUD-associated outcomes (K99 phase) and contributes to development of
comorbid AUD-PD (R00 phase). My published and preliminary data support the hypothesis that microglial
TDAG8 regulates behaviors (ethanol consumption) and physiological (respiratory/cardiovascular) responses
associated with alcohol use (K99), and that ethanol-evoked upregulation of TDAG8 increases susceptibility to
develop comorbid AUD-PD (R00 phase). Aim1 (K99 phase) will test the hypothesis that microglial acid-sensor
TDAG8 regulates ethanol consumption in the “drinking in the dark” (DID) voluntary binge drinking model. Aim 2
(K99 phase) will test the hypothesis that TDAG8 mediates cardiovascular (blood pressure, heart rate, heart
rate variability) and respiratory effects of alcohol use and withdrawal (acute and protracted abstinence). Aim 3
(R00 Phase) will test the hypothesis that alcohol dependence will increase panic-relevant behavioral and
physiological responses to CO2 inhalation (PD-relevant homeostatic stress) in a TDAG8-dependent manner.
Each aim will also investigate neuroinflammation. These aims will elucidate mechanisms of AUDs and
comorbidity with PD. Investigating the intersection of AUD and PD by focusing on shared physiological and
neuroimmune mechanisms will further our understanding of each disorder and lead to novel treatments. This
K99/R00 proposal will provide training in mouse models of AUDs, methods for quantifying neuroinflammation,
and collection/analysis of physiological outcomes. Additionally, it will provide professional development that will
facilitate my transition to an independent academic research position. These aims will provide a foundation for
a successful independent career investigating pathophysiology of AUD and comorbid disorders like PD.

Public health relevance
Project Narrative Alcohol use disorders (AUD) and panic disorder (PD) are highly comorbid and debilitating mental health disorders that may co-occur because of shared underlying mechanisms, such as dysregulated acid-sensing. The goal of this project is to investigate the role of an acid-sensing mechanism in AUD-associated outcomes and determine if dysregulated acid-sensing contributes to development of comorbid PD following alcohol dependence. This study will improve our understanding of acid-sensing in AUDs and the development of comorbid outcomes, and identify novel therapeutic targets to better treat or prevent AUD and PD.